Investigation of Sleep

PROJECT SUMMARY / ABSTRACT: Investigation of Sleep in the Intensive Care Unit (ICU-SLEEP)
Sleep deprivation is among the most common complaints about the ICU experience. ICU sleep tends to be
light and non-restorative (as opposed to deep / restorative sleep), severely fragmented, and distributed
throughout the day and night rather than consolidated into nighttime hours. Sleep deprived patients suffer from
sleep debt, a condition of impaired attention and memory, and cognitive slowing. Sleep disturbances in the ICU
arise not only from light and noise pollution, but also from drugs that interfere with brain activity involved in
restorative sleep. Sleep deprivation has also been suggested as a major modifiable risk factors for acute
encephalopathy, also known as delirium. Delirium is an acute state of confusion that affects up to 80% of ICU
patients, and is one of six leading causes of preventable morbidity and mortality in hospitalized elderly patients.
Many patients who survive delirium experience long-term cognitive impairment and loss of independence.
Current medications used in the ICU to treat sleep problems (e.g. benzodiazepines, antipsychotics) do not
induce natural sleep and do not prevent delirium. In contrast, we have found that the α2-adrenoceptor agonist
dexmedetomidine can induce biomimetic sleep, a brain state whose pattern of electroencephalogram (EEG)
activity, cerebral blood flow, and functional connectivity approximates restorative sleep. Moreover, a recent
large clinical trial in post-surgical patients suggests that low-dose dexmedetomidine given overnight
substantially reduces the risk of delirium. It is unknown whether this benefit is linked to improved sleep, or
whether patients with better sleep while in the ICU have better long-term cognitive outcomes. Our central
hypothesis is that sleep deprivation substantially mediates both the short- and long-term cognitive impairments
associated with delirium in critical illness. To test this hypothesis, our specific aims are designed to
systematically determine 1) the impact of prophylactic dexmedetomidine on sleep quality, 2) the optimal way to
give dexmedetomidine (all night vs at the beginning of the night only), 2) the impact of sleep deprivation on
short-term cognitive function and delirium, and 3) the contribution of sleep deprivation to long-term
neuropsychiatric outcome following critical illness. At the conclusion of these studies, we will have expanded
our knowledge of sleep physiology in critical illness and relationship of sleep with delirium; evaluated a new
preemptive therapeutic strategy to promote sleep and prevent delirium, and developed an understanding of
how sleep impacts neuropsychological outcomes after critical illness. Our studies will thus will provide crucial
guidance for individualized approaches to preserving long-term brain health in this vulnerable patient
population.

Public health relevance
Project Narrative: Investigation of Sleep in the Intensive Care Unit (ICU-SLEEP) RELEVANCE: Sleep deprivation is common and severe in critically ill patients cared for in intensive care units (ICUs), and is hypothesized to be a key modifiable risk factor for delirium and long-term cognitive disability. Dexmedetomidine reduces the incidence of delirium in ICU patients by unknown mechanisms. This project will determine whether dexmedetomidine reduces delirium by improving sleep, whether bolus dosing vs continuous infusion is better, and the relationship of sleep quality to long-term cognitive outcomes.